PHASE III SAFETY AND EFFICACY EVALUATION OF BETASERON IN MULTIPLE SCLEROSIS

The purpose of the study was to determine if the administration of Betaseron (interferon beta 1b) slows the progression of secondary-progressive multiple scleroris. 43 Patients have been enrolled. This is the final number. Data is being analyzed.